2023 International Society for Vaccines (ISV) Annual Congress, October 22-25, Lausanne, Switzerland

Project Summary / Abstract
The International Society for Vaccines (ISV) is a not-for-profit membership organization founded
in 1992 with members from 44 countries, holding annual congresses since 2007. With the ISV
Annual Congress, attended by member and non-member participants from 5 continents, the
Society aims to highlight the very latest ground-breaking developments in vaccine research,
manufacturing, clinical development and implementation, and safety. Plenary sessions are
devoted to current hot topics spanning diverse areas of vaccinology, including vaccines against
challenging targets, T-cell based vaccines, B cell memory establishment, structure-based
vaccine design, mucosal vaccines, and vaccines against emerging infectious diseases. The ISV
Congress, as the main comprehensive non-commercial vaccine meeting, strives to ensure
participation of speakers and delegates from a diverse background (academic, industry,
government, and foundations). Breakout sessions include topics related to adjuvant
mechanisms, One Health, vaccines against zoonotic infections, and next generation vaccines.
Renowned invited speakers in these fields have been and will be invited to set the stage for
each of the plenary topics, complemented with oral presentations selected from the submitted
abstracts. The program will also provide a forum for the next generation of scientists who are
active in the vaccinology field, to present their data in oral or poster presentations, discuss with
peers and senior scientists, and advance their careers, be it in academia, industry, or
government. ISV’s Bright Sparks in Vaccinology competition acknowledges student and postdoc
presentations in parallel sessions of the oral program to support the participation and careers of
next generation vaccinologists. To strengthen their professional advancements, the ISV
Congress, building on its long-standing commitment to mentoring, dedicate a session to career
development opportunities, bringing together junior and senior scientists in an interactive
atmosphere. To stimulate the participation of young scientists, which has always been
successful in the past, the ISV has a policy of inexpensive registration rates for PhD students
and provides Travel Awards to selected junior scientists (based upon abstract submission and
review for quality) to help defray costs of in-person and virtual participation. Prizes for best
presentations or oral abstracts and poster abstracts are a high priority of the ISV Officers, who
volunteer to review and rank all presentations during the ongoing conference to select winners
and runners up based on abstract quality and presentation skills, and present award certificates
to the prize winners.

Public health relevance
Project Narrative There is overwhelming evidence that vaccines are extremely safe, cost-effective, and have an immense benefit on human health. Building on this certitude, the 2023 ISV Annual Congress will embrace forward-looking developments in the exciting field of Vaccinology. In a world that is faced with increasing incidences of rapidly spreading emerging infectious diseases, which can cause an unbearable strain on even the best healthcare systems, there is a pressing need to develop new vaccines against such emerging threats. In addition, there is a dire need to develop highly effective vaccines against “difficult” targets such as Dengue and malaria and, from a One Health perspective, African swine fever virus. The massive, successful roll out of COVID-19 mRNA vaccines has marked a new area in Vaccinology, creating high expectations from the public and governmental health care organizations. Will the mRNA vaccine platform technology live up to these expectations? Furthermore, the 2023 ISV Annual Congress will cover ground-breaking insights in immunology and structural biology that will be instrumental to develop the next generation of safe and highly effective adjuvant systems and vaccine antigens. The 2023 ISV Annual Congress welcomes delegates from all over the world to present and discuss the latest insights in Vaccinology based on scientific grounds.